National Swine Resource and Research Center 1

Project Summary/Abstract
The overall goal of this proposal is to examine the unique role of APP and PSEN1 for progression of the
Alzheimer's disease (AD) by using novel pig models. Alzheimer's disease is the leading cause of dementia and
affects 10% of the U.S. population. Unfortunately, currently no treatment option that can reverse trajectory of the
disease exists. Mouse models of AD have been critical to identify the underlying pathophysiology of this disorder.
However, these models often do not recapitulate all symptoms of the human condition, indicating that additional
animal models of AD are needed to facilitate our understanding of this disorder and accelerate drug discovery
efforts. Pigs are readily available and are considered to be an excellent biomedical model due to anatomical and
physiological similarities to humans. In addition, in comparison to rodent models, pigs have a more similar brain
structure to humans and can perform more complicated cognitive tasks that better model human behavior.
Recent controversial reports on the importance of amyloid plaques for the progression of AD suggest the need
to investigate potential role of APP and PSEN1 that are independent of amyloid plaques. Because specific
polymorphisms of APP and PSEN1 are connected to the prevalence of early onset AD, i.e. Familial Alzheimer's
disease, understanding the roles of APP and PSEN1 could elucidate pathogenesis of AD. While working on the
previous NOT- AG-20-034, we have generated APP knockout pigs and PSEN1 mutant pigs carrying AD
associated allele (ΔE9). Investigating the phenotype of APP-/-, PSEN1+/ΔE9, and APP-/-PSEN1+/ΔE9 pigs should
reveal novel roles of APP and PSEN1 that are not linked to the amyloid deposit in brain. To the best of our
knowledge, our proposed work will offer a novel large animal model to dissect pathogenesis of AD from a new
perspective. We propose two aims. In Aim 1, we will investigate the phenotype of AD pig models at the cellular
and biochemical level. Brain from the pigs will be collected at 6-8 months of age and signs of AD at the cellular
and molecular level will be explored. In Aim 2, we will image the brain of the pig models by using MRI to follow
potential atrophy caused by the genetic modifications. The imaging work will allow us to monitor signs of AD
progression in these pig models and also help us optimize approaches to image the pig brain. Conventional
mouse AD models do capture some AD symptoms; however, due to differences in physiology and size of brain,
it is rare that findings from the models are transferred to the clinic. Diverse animal models reflecting phenotypes
of human AD patient should be invaluable to design novel remedies and translate the findings into the clinic.
Here, we propose to study the role of APP and PSEN1 for the progression of AD by using novel pig models. We
have expertise to complete the proposed experiment within the grant timeframe and the utilization of pig models
for AD can serve as a novel resource to the biomedical community and help advance our understanding and
potential treatment of this major neurodegenerative disorder.

Public health relevance
Project Narrative - Relevance Alzheimer's disease is the leading cause of dementia and affects a significant proportion of population in the U.S. Rodent models have been mainly used to understand pathogenesis of the diseases; however, difference in physiology and brain structure impede application of the findings in clinics. Characterizing novel pig models capturing phenocopies of Alzheimer's disease will significantly assist us on understanding Alzheimer's disease pathology and help identify treatments that can cure this major neurodegenerative disorder.